Harnessing intrinsic cell clocks to control growth & regeneration

Project Summary
Regenerative medicine techniques have become an important option for the many patients suffering from
poorly healing musculoskeletal injuries. Benefits observed from stem cells therapies have, in part, been attributed
to their paracrine actions that initiate appropriate cell-cell communication in the injured tissue. Despite great
strides in understanding molecular controls of spatial cues during tissue patterning, a major knowledge gap
exists regarding the role of timekeeping in coordinated tissue responses. Time-keeping genes involved in the
molecular clock are principally organized to synchronize cells, especially in the day-night rhythms. However, the
oscillatory nature of timekeeping genes may also allow them to contribute to the properties of multipotent cells
that activate upon injury. Despite evidence that clock genes have been shown to play a role in synchronizing cell
states during intestinal regeneration and contribute to the regenerative capacity of basal epithelium and cartilage,
the role of the clock system across multiple cell types during whole limb regeneration is unknown. This proposal
aims to uncover and exploit the relationship between clock genes and regeneration during development, with
the goal of controlling the speed and capacity for tissue regeneration in the Xenopus laevis. Xenopus larvae are
capable of tail regeneration and exhibit regenerative and regeneration-incompetent developmental stages,
making them a useful model for interrogating the process of tissue repair. Xenopus also develop quickly and ex
vivo, permitting easy monitoring of morphology and the outcomes of genetic manipulation. Although mammals
have a more limited capacity for self-regeneration, understanding the role of timekeeping genes in Xenopus can
provide important insights into how we may control tissue regeneration in humans. In Aim 1, biological time-
keeping machinery will be characterized in cells of the regenerative and non-regenerative Xenopus tail using in
vivo DNA reporters and single-cell transcriptomics. Single-cell transcriptomics will be used to define which cell
type(s) act as drivers of time keeping processes to maintain the collective actions of greater than 40 cell types
during tail regeneration. Aim 2 will determine how the clock gene system affects regenerative capacity and the
speed of regrowth by assessing timekeeping control at both network and single-gene levels. Regenerative
capacity will be evaluated when the clock gene network is amplified or damped using small molecule treatments.
CRISPR/Cas9 clock gene overexpression and knock downs will be used to determine the role of five core time-
keeping genes known to affect regeneration in other tissues. The effects of small molecules and clock gene
knockouts on the cell synchronization landscape will be monitored using single-cell sequencing. This project will
be the first to closely characterize the clock system in whole-limb regeneration and may lead to greater insights
for improving tissue repair and reprogramming cells during integration, like that required in clinical stem cell and
living tissue transplantations.

Public health relevance
Project Narrative Tissue repair after injury is a carefully orchestrated process, often with imperfect outcomes. Many therapeutic approaches use stem-cell derived cell populations to regenerate tissues but suffer from poor integration between new cells and existing structures, possibly due to lack of communication and coordination between those cells. Building upon principles from developmental biology, genetics, and regenerative medicine, this project aims to uncover the role of timekeeping genes in cell-cell cooperation during tissue repair and learn to modify the activity of those genes, thus establishing a new roadmap to improve tissue repair and regeneration in biomedical settings.